Unveiling CTL1 as the Key Choline Transporter in Oligodendrocytes: Implication for Myelin Formation and Maintenance

Abstract
Oligodendrocytes rely heavily on choline to generate myelin membrane, as choline serves as a precursor to
essential membrane phospholipids and signaling lipids. Additionally, choline is a source of methyl groups
needed for many steps in metabolism and regulation of gene expression. Cells have a limited capacity to
synthesize choline; thus, they must acquire it from an extracellular source. Clinical importance of choline
intake in myelination has been demonstrated. For instance, prenatal choline deficiency correlates with
reduced white matter. Choline supplement has been shown promise in enhancing myelin repair in patience
with multiple sclerosis. Despite the recognized significance of choline, we currently have limited
understanding of how oligodendrocytes acquire this essential nutrient. The long-term goal of our study is to
elucidate the mechanism of choline import and the implications in regulating oligodendrocyte myelination.
The expression of choline transporter-like 1 (CTL1) in oligodendrocyte has been reported previously, peaking
during active myelination and remaining sustained in adult brain. Since oligodendrocytes do not express CHT,
the high-affinity transporter, these observations suggest the role of CTL1 as a choline transporter in
oligodendrocytes. Supporting this, a recent human study links non-sense CTL1 mutations to early onset
progressive white matter atrophy, highlighting the importance of CTL1 during myelination. The function of
CTL1 in oligodendrocytes has not been elucidated. In this study, we aim to test the hypothesis that CTL1 is
the main choline transporter in oligodendrocytes and plays a crucial role during oligodendrocyte generation
and myelination. Two specific aims are proposed.
Aim 1 Do oligodendrocytes acquire choline through CTL1, and what are the implications on myelin lipid
synthesis and oligodendrocyte differentiation? We will use MALDI-TOF MS and lipidomic analysis to
determine the impact of CTL1 loss on choline import and myelin lipid composition in oligodendrocytes. We
will also use scRNA-seq transcriptome analysis to define the impact of CTL1 loss on oligodendrocyte
differentiation progression and gene expression
Aim 2 Is CTL1 important for oligodendrocyte generation, myelination and myelin maintenance in vivo?
Oligodendrocyte lineage-specific PDGFaR-CreER;Ctl1fl/fl;EYFP and PLP-CreER;Ctl1fl/fl;EYFP
mice will be used to temporally delete CTL1 in OPCs and mature oligodendrocytes, respectively.
Immunohistochemical, biochemical, and ultrastructural EM analyses will assess the impact of CTL1 loss on
oligodendrocyte lineage development, myelination, and myelin maintenance.
Overall, the study's findings have the potential to significantly advance our understanding of the importance
of choline metabolism in myelin biology and provide new insights into developing targeted therapeutic
strategies to enhance myelin repair in disorders associated with myelin dysfunction.

Public health relevance
PROJECT NARRATIVE Recent studies have shown promise in choline supplementation for enhancing oligodendrocyte myelin repair in patients with demyelinating diseases in the CNS, however, the mechanism by which oligodendrocytes utilize choline for myelin synthesis is poorly understood. Through our proposed study, we aim to achieve two key objectives: 1) Understand the mechanism by which oligodendrocytes acquire choline and 2) evaluate the importance of choline import in oligodendrocyte development, myelin synthesis, and maintenance. By addressing these objectives, we anticipate gaining crucial insights into the role of choline metabolism in devising therapeutic strategies for the treatment of demyelinating diseases within the CNS.